Using CBPR to Adapt a Culturally-grounded Prevention Curriculum for Urban America

DESCRIPTION (provided by applicant): American Indian (AI) families now living in urban areas experience disproportional health disparities associated with substance abuse and risky sexual behavior but few evidence-based prevention approaches exist to prevent, reduce and eliminate health disparities among this rapidly growing population. Family disruption, stresses related to poverty and rural-to-urban migration, and loss of cultural and social connections frequently operate as pathways to adverse health outcomes among AI families. By strengthening family functioning (parental involvement, family support, parental monitoring, and parent-child communication), a parenting intervention can help parents strengthen culturally relevant parenting skills that are consistent with promoting their children's health and well-being, and help them serve as direct sources of influence in reducing their children's risk of substance use and risky sexual behavior. The proposed study draws upon the project team's research, conducted at an NCMHD Center of Excellence, on the social determinants of AI families' behavioral health, their salient risk and resiliency factors, culturally appropriate strategies for resisting risk behaviors, and systematic methods for culturally adapting prevention programs. The aims of the study are to create and test a culturally grounded parenting intervention for urban AI families through a modification of an existing prevention program, Families Preparing the Next Generation (FPNG). The adaptation will employ a Cultural Adaptation Model for adapting programs for new target populations in ways that increase cultural fit while maintaining fidelity to core components of the original program. The intervention will be adapted, piloted, evaluated, culturally validated, revised accordingly, and tested in a randomized control trial (RCT) involving 600 families (300 intervention, 300 control) in partnership with the three largest urban Indian centers in Arizona. Ecodevelopmental Theory provides the framework for identifying parental, family, peer, community and cultural influences on youths' substance use and risky sexual behavior. CBPR methods will be used to adapt the intervention, using feedback from focus groups of urban AI parents, AI professionals and prevention experts, and through close collaboration between the designers of the original intervention and staff of the urban Indian centers, thus increasing the capacity of those centers to provide future parenting interventions. In addition to testing the intervention's efficacy, we will assess whether and how the participants' connection to native culture and identity influences the interventions effects, and whether changes in overall family functioning lead to specific parenting practices directed at reducing their children's risk behaviors. These models and theory can inform the design and implementation of more effective, culturally relevant interventions. The resulting prevention intervention will address the needs of an under-served group severely affected by health disparities, strengthen families and help them to avoid familial and individual dysfunction, and advance knowledge on effective translational research strategies for adapting prevention interventions for ethnically diverse families.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed study responds to a need, identified by urban Indian coalitions in Arizona and across the nation, for innovative culturally grounded prevention program adaptation for urban American Indian (AI) families. Public health efforts to address unacceptably high levels of substance use and risky sexual behavior among urban AI youth can be advanced through the creation of an intervention that focuses on effective parenting strategies tailored to the cultural and social forces that urban AI families face. The CBPR methodology of the study not only integrally involves community partners and community members in the design and testing of the intervention, it builds institutional capacity for sustaining the development and delivery of this and similarly designed culturally grounded prevention interventions. Principal Investigator/Program Director (Last, First, Middle): Kulis, Stephen The proposed study responds to a need, identified by urban Indian coalitions in Arizona and across the nation, for innovative culturally grounded prevention program adaptation for urban American Indian (AI) families. Public health efforts to address unacceptably high levels of substance use and risky sexual behavior among urban AI youth can be advanced through the creation of an intervention that focuses on effective parenting strategies tailored to the cultural and social forces that urban AI families face. The CBPR methodology of the study not only integrally involves community partners and community members in the design and testing of the intervention, it builds institutional capacity for sustaining the development and delivery of this and similarly designed culturally grounded prevention interventions. __SpecificAimsTextDelimiter__ Principal Investigator/Program Director (Last, First, Middle): Kulis, Stephen SPECIFIC AIMS In many American Indian (AI) communities, morbidity and mortality rates of many preventable conditions are disproportionately high, including health disparities related to substance abuse and the closely associated risks of engaging in risky sexual behavior (Indian Health Service [IHS], 2001, 2005; Rutman et al., 2008). The lack of infrastructure on AI reservations, and of culturally appropriate prevention and intervention services outside the reservations, have negatively impacted AI communities. Youth from AI families have higher rates, earlier onset, and more severe consequences of substance abuse than their non-native counterparts, yet are more likely to perceive minimal risk of harm from substance use (Moncher, et al, 1990; SAMSHA, 2004). Compared to non-Hispanic Whites, AI adolescents are more likely to have multiple sex partners, become pregnant, have sexual intercourse before the age of 13, and are less likely to receive HIV/AIDS education (Rutman et al., 2008). These disparities extend to urban American Indians, who are now a majority of the AI population (Castor, et al., 2006; National Urban Indian Family Coalition, 2008). Feeling connected with family and communicating with adult family members are protective factors against risky behaviors among urban AI and other first nations' youth (Devries, et, al, 2008; Marsiglia, et al, 2006). This suggests the need for primary prevention efforts targeting AI families to thwart the onset of youth substance abuse and its subsequent adverse effects on risky sexual behavior. The proposed study addresses these disparities by developing culturally grounded prevention efforts for urban AI families in the southwestern U.S., a large and growing population seldom targeted through existing evidence-based prevention efforts. The goal of the study is to improve family functioning and teach specific parenting skills that will provide urban AI parents with strategies for preventing adolescent substance use and risky sexual behavior. The study will produce, validate, pilot, implement and assess the feasibility and efficacy of a culturally grounded adapted parenting intervention. The study utilizes community based participatory research methods to apply principles of culturally grounded program adaptation, and will involve translational research, drawing on the research team's prior studies on the social and cultural determinants of risk behaviors for urban AI youth and expertise in culturally grounded program adaptation. The study will produce knowledge about effective prevention at the family system level for under-served urban AIs, a group possessing unique resiliencies and cultural resources as well as risk factors. Aim 1 is to adapt a promising parenting education intervention for urban AI parents, following the principles and methods of the Cultural Adaptation Model (Castro, Barrera, & Martinez, 2004), to help them prevent their children from engaging in substance use and risky sexual behavior. The project will modify Families Preparing a New Generation, a culturally grounded parenting program based on two Model Programs, Familias Unidas and keepin' it REAL. These interventions have been demonstrated effective in improving family functioning and preventing youth substance use and risky sexual behavior (Kulis, et al., 2005; Pantin, et al., 2009). We propose to adapt Families Preparing a New Generation to reflect the ecological risk and resiliency factors, cultural norms, and social determinants of substance use and risky sexual behavior among urban AIs (e.g., Kulis, et al., 2006). We will create a cognitively appropriate adaptation, i.e., one that uses culturally appropriate language and delivery formats, as well as content that reflects salient social and cultural determinants of urban AI substance use and risky sexual behaviors. Potential affective issues with the adapted curriculum will be addressed by incorporating empirically validated and culturally appropriate strategies for resisting risky behaviors (Okamoto et al., 2004), and by drawing on effective health promotion strategies that integrate approaches consistent with Indian culture and healing practices (Stiffman, et al. 2005). To ensure the validity of the curriculum, we will follow a community based participatory research approach that integrally involves AI key informants in an evaluation of a field pilot of the adapted curriculum. Addressing cognitive and affective issues, we will produce a comprehensive culturally adapted parenting prevention intervention for urban AI families. Aim 2 is to compare the culturally adapted parenting intervention with a control condition in a randomized control trial to determine the feasibility, efficacy, and effect size of the intervention. The trial will be conducted at the three Indian centers that provide services to Arizona's largest clusters of urban American Indian families. Parents seeking help at the centers will be recruited for the study and randomized into the culturally adapted parenting intervention or a control group that attends family health informational sessions. Through a pre-test / post-test design we will test whether the adapted parenting intervention produces more desirable short-term and 12 month outcomes than the control group in family functioning, effective parenting, and improved communication with children about risky behaviors. Analyses will also test for moderators of the intervention's effects: whether effects differ depending on the cultural orientations of the participants (e.g., strength of Native identity, involvement in Indian cultural practices). The study will produce an intervention that addresses the prevention needs of this under-served group (Grossman, 2003). Study findings could be used to refine the intervention for replication with urban AI families in other urban areas.